The impact of the aging immune system on periodontal disease

Project Summary
This is an application for an administrative supplement to an existing Mentored Clinical Scientist Research
Career Development Award (K08) awarded to Dr. Daniel Clark. Dr. Clark has been training to establish himself
as an investigator in basic science research of osteoimmunology, and this award will provide Dr. Clark with the
support and opportunities necessary to reach his career goal of being an independent researcher. In pursuit of
his career goal, the K08 award will allow Dr. Clark to: (1) to become an expert in osteoimmunology; (2) develop
an independent research program through novel application of osteoimmunology to the investigation of
periodontal disease; (3) create a productive and impactful publication record; (4) enhance grant writing skills and
create a record of successful utilization of past and current awards. Towards his career goal, Dr. Clark has
established a transdisciplinary team to provide their expertise in research training and mentorship in career
development. Immune system dysfunction increases with age and is associated with an increased prevalence
and severity of inflammatory conditions in elderly populations, including periodontal disease. The cellular and
molecular process regulating the inflammatory response that become perturbed by age are unknown. Dr. Clark’s
long term goal is to identify cellular and molecular targets for immunomodulatory treatment of periodontal
disease. The objective of this proposal is to understand how a key cellular regulator of the innate inflammatory
response, macrophages, interacts with mesenchymal stem cells (MSCs) and Th17 cells, to regulate inflammation
in bone and how these processes become dysregulated with age. Dr. Clark will utilize primary cell lines from
young and old mice and a periodontal disease mouse model to investigate (1) the extent to which macrophages
and MSCs interact through triggering receptor expressed on myeloid cells-2 (TREM2) to downregulate
inflammation; (2) the extent to which an aged macrophage phenotype drives pathogenic Th17 cell expansion;
(3) and demonstrate the effect of immunomodulation with cell-based therapeutics that target age-related
perturbations to rejuvenate the immune response in periodontal disease. Further single cell analysis and
bioinformatics techniques will produce transcriptomic datasets to identify gene expression signatures associated
with aging and inflammatory dysregulation. Findings from this project will improve our understanding of immune
regulation in bone, introduce novel targets for therapy, and provide Dr. Clark with a novel independent research
program.

Public health relevance
Project Narrative Proper regulation of inflammation within bone is critical for preventing disease and healing from injury. A dysregulated immune response becomes more prevalent in elderly populations and results in a susceptibility to numerous conditions, including periodontal disease. The goal of this project is to understand the age-related perturbations that occur to the cellular and molecular regulators of the innate immune response in bone.